Predictors and determinants of pediatric immunity (Peds)

The unique characteristics of the human immune response in early life are critically important and yet remain poorly understood. Our overarching hypothesis is that the pediatric immune system is not just a naïve adult immune system but is fundamentally different. The challenges associated with pediatric studies, including small sample volumes and rare diseases, have been barriers to meaningful progress in the field, and there are numerous basic questions that remain unaddressed. By taking a synergistic multi-pronged approach, we aim to better understand the unique biology of pediatric immunity and its implications for normal immune function as well as a variety of disease states. The central hypothesis addressed in this program project is that genetics, developmental stage, and immune challenges shape the trajectories of antigen-specific and -agnostic homeostatic set points that determine future immune response quality and quantity. Our three projects, with support of our four cores, will synergize in addressing the following overarching and interconnected scientific aims. Aim 1: Uncover genetic and neonatal determinants of temporally ultra-stable, individualistic immune states established at infancy. Aim 2: Determine dynamic immune parameters remodeled throughout the pediatric age range by immune exposures, developmental variables, and genetics. Aim 3: Elucidate how baseline immune states predict and determine responses to immune challenges in an age-dependent manner in childhood. Our program will leverage multiple human subject cohorts that will offer important insights with broad relevance. Together, this work will enable us to construct a ‘growth chart’ of sorts for the pediatric immune system that will better enable identification and assessment of genetic, environmental, and developmental conditions that deviate immune trajectories into unhealthy ranges.

Public health relevance
OVERALL PROJECT NARRATIVE The ‘Predictors and determinants of pediatric immunity’ (Peds) Program Project Grant will advance our understanding of how genetics, developmental stage, and immune challenges shape the pediatric immune system, with an experimental emphasis on leveraging cutting-edge, multimodal analyses of very small blood samples. Our Projects cover broad pediatric patient cohorts that will enable us to learn from pediatric responses to vaccines, immune set points in the first year of life for premature and full-term babies, and genetic immune diseases of childhood. Together, this work will enable us to construct a ‘growth chart’ of sorts for the pediatric immune system that will better enable identification and assessment of genetic, environmental, and developmental conditions that deviate immune trajectories into unhealthy ranges. Modified Project Summary/Abstract Section PROJECT 3 - PROJECT SUMMARY This project is designed to illuminate pediatric immunology through genetic analyses in children suffering from known or suspected inborn errors of immunity (IEIs). Remarkable advances in next-generation sequencing (NGS) of genomic DNA have facilitated the identification of causative genes for over 450 distinct IEI, and accompanying studies of the functional consequences of the underlying genetic variants have led to unprecedented insights into immune function in health and disease including novel precision therapies. We will build from (a) cohorts of three defined IEIs caused by mutations in the genes encoding phosphoinositide 3-kinase delta (PI3Kd), STAT1, or ELF4 and (b) our extensive experience and infrastructure in the Pediatric Genomics Discovery Program (PGDP) at Yale to discover novel gene defects in patients with suspected but unsolved IEIs. This will enable us to test our central hypothesis that rare, deleterious variants in genetic determinants of the core pathways of (i) PI3K/mTOR or (ii) interferon responses derail healthy immune homeostasis and development during childhood by perturbing critical signals that govern immune cell states. These two pathways emerged as prominent biological signals in both the core pathways identified in preliminary data from Project 1-2 and in IEI cohorts. Thus, for each pathway, we will combine unprecedented depth of profiling of peripheral blood immune cells from defined IEI patients versus healthy controls with new gene discovery to functionally assess genetic determinants of PI3K/mTOR- and interferon-related pathway impacts on immune health. In Aim 1, we will focus on PI3K/mTOR and assess immune landscapes of a cohort of patients with ‘Activated PI3Kd Syndrome’ longitudinally, novel genes impacting this pathway from our preliminary data, and candidate genes identified in newly enrolled IEI patient cohorts. In Aim 2, we will focus on interferon pathways and assess for our defined IEI cohorts STAT1 gain-of-function patients and ‘Deficiency in ELF4, X-linked’ patients longitudinally, together with new candidate genes. Our multiomics approaches will match those of Projects 1 and 2 for optimal data integration supported by the Cores’ expertise in single-cell sequencing and computational approaches, functional studies at the single-cell level with CyTOF, and longitudinal immune signature landscapes with spectral flow cytometry. Together, Project 3 will advance the Peds Program Overall aims by uncovering genetic determinants of cellular programs in childhood that are temporally ultra-stable or characteristically dynamic, thereby defining the functional effects of these programs on immune health. Modified Specific Aims Section PROJECT 3 - SPECIFIC AIMS Children who suffer from inborn errors of immunity (IEI) caused by single-gene mutations can present with a wide range of phenotypes including overwhelming infections and uncontrolled inflammatory states. The genes and pathways disrupted in IEIs offer great promise for fundamental insights into how healthy immune systems develop and remodel with age. Advances in genomic DNA sequencing have facilitated the identification of causative genes for nearly 500 distinct IEIs. Still, the majority of IEI patients remain undiagnosed, and a broad, systems-level synthesis of discoveries from IEIs into a conceptual framework that highlights core regulators of healthy immune setpoints is lacking. In Project 3, we will leverage our expertise investigating IEIs and build from the motivating preliminary data described in the Peds Overall strategy. In particular, data from analyses of pediatric and infant populations highlight two central pathways that we will functionally dissect through study of IEI patients with monogenic defects: (i) PI3K/mTOR and (ii) interferon pathways (pathways highlighted as having functionally relevant trajectories from infancy to childhood, as identified in preliminary data from Projects 1 and 2). Our team originally described IEIs from gene defects that affect these pathways and is therefore well positioned to thoroughly dissect these and related genetic determinants of healthy pediatric immune trajectories. To do this with multiomics/computational support by the Cores, we will systematically and longitudinally assess immune profiles in subjects with known and novel causal IEI gene variants affecting these two pathways and compare these temporal profiles with those from Projects 1 (children 0.5 to 14 years from two geographical locations) and 2 (pre- and full-term infants) to assess impacts of functional disruption in these circuits. Central Hypothesis: Rare, deleterious variants in genetic determinants of the core pathways of (i) PI3K/mTOR or (ii) interferon responses derail healthy immune homeostasis and development during childhood by perturbing critical signals that govern immune cell states. We will test this hypothesis in two aims: Aim P3.1: Dissect the immune cell state aberrations in patients with IEIs affecting the core immune developmental process of PI3K/mTOR. Rationale: Genes mapping to phosphoinositide 3-kinase (PI3K), which regulates mechanistic target of rapamycin (mTOR) and downstream effectors, stand out as particularly relevant in infancy in preliminary data from Projects 1-2. Thus, we will dissect how genetic perturbations in this pathway derail healthy immune trajectories through two subaims: Aim P3.1a: Determine how PI3Kd governs immune setpoints and trajectories in a defined cohort of patients with Activated PI3Kd Syndrome (APDS), an IEI caused by gain-of-function (GoF) mutation in PI3Kd. Although we reported this IEI approximately 10 years ago, a broad unbiased assessment of immune cell states over time in pediatric APDS versus healthy controls is lacking. We will take a systems immunology approach that aligns with the approach taken for other cohorts in Projects 1 and 2, namely using CITE-seq plus ASAP-seq and CyTOF for profiling and functional assessments in samples collected longitudinally over the five-year grant. Aim P3.1b: Define novel causal gene mutations affecting the PI3K/mTOR pathway in pediatric patients with unsolved immune diseases. Beyond PI3Kd, we will mechanistically dissect novel gene variants impacting this pathway in pediatric IEI patients utilizing in vitro functional studies paired with multiomics profiling. This will include investigation of (i) variants we have already defined in Project 3 preliminary data in suspected IEI patients as well as additional novel variants affecting PI3K/mTOR that we will define through a combination of (ii) unbiased phenotype-first, forward genetics in newly enrolled pediatric patients and (iii) mining of our existing database of genomic sequences from “unsolved” early-onset IEIs for variants in genes affecting this pathway prioritized based on data in Projects 1 and 2. Aim P3.2: Determine perturbations in the immune landscape of IEI patients with monogenic defects in interferon circuits. Rationale: Our Overall preliminary data in pediatric patients described in more depth in Project 1 highlight the interferon (IFN) pathway as characteristically dynamic in early life with high signatures in early life that gradually reduce with age. Project 3 will test the prediction that genetic perturbation of the IFN pathway will inform the underlying basis for how the pathway normally functions to enforce healthy immune setpoints; this further highlights the synergy between our projects. We will pursue two subaims: Aim P3.2a: Determine how STAT1 governs immune setpoints and trajectories in a defined cohort of patients with gain-of-function mutation in STAT1. STAT1 is a key transcription factor activated by IFN, and we will perform longitudinal multiomic analyses on a defined cohort of STAT1 GoF patients as described in Aim P3.1a. Aim P3.2b: Define novel causal gene mutations affecting the IFN pathway in pediatric patients with unsolved immune diseases. Beyond STAT1, we will mechanistically dissect novel genes driving IEIs that intersect with IFN biology to disrupt healthy immune states. As in Aim P3.1b, this will include (i) variants in ELF4 we have defined in IEI and known to affect IFN biology and (ii) mining our in-house genomic DNA sequencing data on “unsolved” cases. Modified Public Health Relevance Section No changes. Modified Project Summary/Abstract Section CORE 2 - SUBJECTS & SAMPLES CORE - SUMMARY This research program project grant (PPG) is designed to provide much-needed insight into pediatric immunology. A unifying feature of the research approach for all three Projects of the PPG is the utilization of samples and associated meta data from broad human subject cohorts, each one distinct and carefully selected to achieve the objectives of the Projects. Given the prominence of these cohorts to the PPG, we have designed this Subjects & Samples Core to provide centralized oversight of all aspects of human subjects studies, from regulatory administration to enrollment of participants to handling of biological samples to management of demographic and clinical meta data. This core will be responsible for overseeing these and other related tasks and for disseminating timely communications about the progress of these human cohorts to the other Cores and individual Projects across of the PPG, thereby stimulating discussion and enhancing synergy between investigators. Modified Specific Aims Section CORE 2 - SUBJECTS & SAMPLES CORE - SPECIFIC AIMS A vital aspect of this research program project grant (PPG) is the integration of unique participant cohorts and sample sets with scientific investigation in order to address important outstanding questions in pediatric immunology. These sample sets and cohorts are: 1) previously biobank pediatric development and vaccination samples, 2) Michigan cohort, 3) term and premature newborn cohort, and 4) inborn errors of immunity (IEI) cohort (spread across four recruitment sites: Yale, NIH/NIAID, and Phoenix). As human samples and cohorts play a central role in each of the Projects of this proposal, we have developed a distinct Subjects & Samples Core that will take advantage of existing frameworks to focus on all matters related to participants and their samples. The Subjects & Samples Core will thus be utilized by all three Projects to coordinate their respective study cohorts and will interface intimately with the Data and Admin Cores to ensure seamless access to necessary data and samples for investigators across the PPG. Aim 1: Identify and enroll participants for study in this PPG a) Manage IRB protocols • Maintain and update domestic IRB protocols for all four studies • Maintain single IRB across domestic sites with the same study • Confirm compliance with IRB protocols b) Guide participant identification and recruitment • Support communication between study coordinators and enrollment sites • Ensure that local sites have appropriate access to participants c) Oversee consent and enrollment • Ensure appropriate training for local enrollment coordinators • Monitor enrollment milestones d) Ensure collection and recording of participant demographics, including relevant meta data • Oversee use and management of participant databases • Coordinate organization, management, back-up and secure storage of participant data Aim 2: Obtain, process, and manage samples and data from participant cohorts e) Sample collection, handling, and storage • Oversee sample handling logistics for each study, including MTAs and appropriate biohazard levels • Maintain appropriate biorepository records using FreezerPro LIMS f) Distribution of samples and associated data to relevant Projects or Cores • Serve as central hub for sample receiving and distribution across the PPG • Provide collaborating researchers within the PPG secure access to appropriate participant demographic, clinical, and other related meta data g) Facilitate communication between participants and investigators • Coordinate communication when results from this research protocol have clinical implications • Ensure regulatory and IRB compliance of communication Synergy with Peds Overall Aims: The formation of a dedicated Subjects & Samples Core is designed to provide a centralized, smooth framework for the conduct of human subjects studies, which forms the basis of the research approach of this PPG. Additionally, by placing oversight of all human subjects-related matters into a dedicated Subjects & Samples Core we are aiming to not only streamline administrative tasks, but also to disseminate awareness of the progress of various cohorts across the PPG, thereby promoting crosstalk and exchange of ideas between Projects. Modified Public Health Relevance Section No changes. Modified Project Summary/Abstract Section No changes. Modified Specific Aims Section CORE 4 – Data Management and Analysis Core (DMAC) – SPECIFIC AIMS Projects 1-3 will generate multimodal, high-throughput single cell data characterizing the gene expression, surface protein expression, chromatin accessibility, and TCR and BCR repertoires of immune cells obtained from blood samples of a broad set of pediatric cohorts, including longitudinal samples. The cohorts include pre-term and full-term neonates during the first year of life (Project 2), individuals from early childhood to adolescence beyond the first year of life exposed to immune perturbations in the form of natural infections and vaccination (Project 1), and individuals with inborn errors of immunity (Project 3). The overarching goal of the Program is to leverage the detailed characterization of pediatric cohorts to address key gaps in our current understanding of immune development, genetic and environmental predictors and determinants of immune set points in childhood, and the molecular underpinnings of inborn defects in the immune system. Addressing these gaps would help identify strategies for immune modulation early in life as well as for developing better vaccines. The success of this program spanning cohorts across multiple sites and involving complex multimodal single cell and other advanced assays will rely on optimal study design for reproducibility and efficient resource usage, the availability of a robust infrastructure for data management and sharing, and state-of-the-art bioinformatics pipelines for processing and analyzing the data generated. Integrative data analysis and modeling, capable of incorporating data from different modalities within a project as well as across projects, will be needed to develop an overarching conceptual framework of pediatric immune development for the generation of testable hypotheses and useful predictions. Finally, a streamlined strategy focused on timely sharing of data and analysis results will be crucial to maximizing the Program’s impact by allowing the broader scientific community to build upon the data and results generated by the Program. The Data Management and Analysis Core (DMAC; Core 4) will support the overarching goals of the Program by providing all the above-mentioned services in a standardized and centralized fashion. Task C4.1: Provide a system for clinical and research data management, storage, and sharing The DMAC will provide a REDCap-based Subject Management System capable of handling data for the subjects enrolled at Yale as well as pre-anonymized sample data from other study sites (e.g., data from the Michigan study site). The system will provide a streamlined, centralized mechanism for sharing data across the projects for downstream analysis and facilitate data sharing via public repositories including ImmPort and Gene Expression Omnibus. DMAC-led data and resource sharing will focus on ensuring that the published analyses can easily be replicated by the broader community by providing software containers that replicate the exact computational environment. Task C4.2: Provide biostatistics, bioinformatics, and integrative data analysis support and consultation Task C4.2A: Provide biostatistical support and consultation for study design The DMAC will provide biostatistical support to all the projects, including in the early stages of study design and during the development of data analysis plans to ensure reproducibility, appropriate randomization and sampling, and responsible statistical interpretation. Task C4.2B: Processing and analysis of longitudinal multimodal, high-throughput single cell and omics data The DMAC will utilize and develop and implement state-of-the-art bioinformatics pipelines for the analysis of the multimodal datasets. The centralized effort will ensure standardization and consistency across projects and datasets, facilitating integrative analysis. Task C4.2C: Integrative analysis across data modalities and projects The DMAC will analyze individual “omics” datasets to identify stable immune signatures and signatures that change in response to infection and vaccination, including those predictive of serological responses to vaccination. Thereafter, the core will support the integration of the signatures across “omics” datasets and projects to develop a coherent picture of and testable predictions regarding pediatric immune development from infancy to adolescence. Modified Public Health Relevance Section No changes